Pittsburgh Liver Research Center

Abstract
The inception of the Pittsburgh Liver Research Center (PLRC) in 2016 was the result of high enthusiasm of the
leadership, which came with strong institutional support and commitment in the form of resources from both the
University of Pittsburgh Medical Center (UPMC) and the University of Pittsburgh (UP). PLRC truly represents a
successful partnership between UPMC, a pioneer in healthcare delivery and the UP, a renowned leader in research,
discovery, education, and innovation. With the centralized mission of promoting the understanding of the cellular and
molecular basis of hepatobiliary injury and repair, the PLRC has brought together a very strong group of investigators
and clinicians engaged in basic and translational liver research and in the delivery of clinical care to liver patients. Over
the last 2 years, PLRC has brought together the membership composed of 80 investigators and clinicians (49 full
members) representing multiple departments and institutions within the UP and UPMC, as one community. This was
facilitated by regular networking, physician-basic scientist roundtables, seminars and workshops, to enrich the
environment making it conducive to strengthening existing collaborations and initiating new partnerships. PLRC has
organized itself into 3 highly functional scientific interest groups (SIGs)−Regenerative Medicine, Chronic Liver Diseases,
and Liver Tumorigenesis−with overlapping membership and regularly scheduled interactions facilitating a scientifically
fertile environment for dialogue through a rather novel Enrichment program. SIG roundtables allow recurring dialogue
between physicians and scientists on carefully selected topics and foster collaborations and more meaningful research. To
enable pioneering and impactful science in the labs of PLRC investigators, we have established 3 highly integrated
biomedical research cores and a clinical component that provide state-of-the-art and innovative services to enable cutting-
edge research and translation from bench to bedside. Likewise, PLRC identifies new investigators and, through Pilot and
Feasibility programs, supports their research and development as independent investigators through longitudinal
mentorship and offering career and professional development activities in addition to scientific support. Special awards
via institutional support allow funding of team science projects that promote physician and basic scientist interactions,
technology development and commercialization. All of the above services and functions that are aimed at discerning
complex tribulations in hepatic health and disease via research in the area of hepatobiliary injury and repair through
promoting innovative, collaborative inter-, trans and multi-disciplinary research, to make a sustainable impact on human
health, are ensured by a strong leadership and organization provided under the aegis of an Administrative Core. In fact,
the PLRC leadership has leveraged many existing strengths of the institute like CTSI, Innovation Institute and the Coulter
program as well as formed alliances with existing institutes like the University of Pittsburgh Cancer Institute, Starzl
Transplant Institute and the McGowan Institute of Regenerative Medicine to expand services and benefits provided by the
PLRC to all its members and eventually better their science, translation and commercialization. Thus, eventually, through
their integrated services and programs, the long-term objective of the PLRC is to promote impactful science in the area of
hepatobiliary pathophysiology and improve the hepatic health and care, both locally and globally.

Public health relevance
Elucidating the cellular and molecular basis of hepatobiliary injury and repair will yield novel and innovative cures to practically any hepatic disease. At the Pittsburgh Liver Research Center (PLRC), we enable this line of investigation through: services provided by the integrated biomedical research cores; clinical component that advises on meaningful research while allowing translation; by identifying, funding and mentoring early stage investigators; while providing enrichment through educational sessions and promoting interactions between physicians and scientists across desprtments.